HIV/AIDS Clinical Trials Units University of Cape Town CTU 2020 to 2027

Program Director/Principal Investigator (Last, First, Middle): Bekker, Linda-Gail
The University of Cape Town Clinical Trials Unit (UCTCTU) is based at the Desmond Tutu
HIV Centre in Cape Town, South Africa. The CTU’s primary goal is to provide a highly
efficient, effective, and integrated Clinical Trials Unit that contributes to the global epidemic
control of HIV and Tuberculosis. The UCTCTU has the capacity, capability and competence
to deliver world standard clinical trials in HIV, tuberculosis, and STI treatment and prevention
in a broad range of populations.
One of the core advantages of the UCTCTU is its location in Southern Africa. Recent reports
estimate that of the 36.9 million people living with HIV globally, 25.7 million are living in sub-
Saharan Africa. Thus, the subcontinent faces significant challenges in delivering treatments
and methods of prevention but also stands to make a significant contribution to innovation
and progress. In addition to its key location, the UCTCTU provides world-class scientific
leadership, administrative support, and common infrastructure. This enables four well-
established, diverse Clinical Research Sites to contribute cohesively to the research agenda
of the four NIH funded networks. Each of the Clinical Research Sites are located in
communities around Cape Town where the burden of HIV, tuberculosis and other diseases
is high. Thus, the research agenda of the NIH is being fulfilled in communities where
treatment and prevention is needed most.
Based at the University of Cape Town, this CTU is accommodated and supported by an
institution that is consistently ranked the best university in Africa, with a Health Science
Faculty recently ranked in the Top 100 globally. All Clinical Research Sites have access to
high-quality laboratories, with arguably the finest scientific expertise and best medical
diagnostic and investigative resources in the country. The consortium of Clinical Research
Sites are all components and affiliates of the University of Cape Town and thus share
the same or similar management platforms, supporting and amplifying efficiencies and
synergies.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Bekker, Linda-Gail The University of Cape Town Clinical Trials Unit (UCTCTU) based at the Desmond Tutu HIV Centre, University of Cape Town has four unique, expert and integrated clinical research sites which are ready and willing to contribute to the research priorities of the 4 NIH funded clinical trial Networks namely the ACTG, IMPAACT, HPTN and HVTN. Collaboratively this clinical trials consortium will utilise the experience and expertise of the core and it’s sites to efficiently and effectively promote the research and development of new innovations in treatment, prevention and management of HIV, tuberculosis and related conditions.